Longitudinal Imaging of Maternal Exercise and Exerkine Effects on Offspring Metabolism

Project Summary/Abstract
Exercise is increasingly being seen as an effective form of therapy against many diseases. Maternal exercise,
especially during pregnancy, has long-lasting effects on childhood wellbeing. Part of these beneficial effects
come from the secretion of exercise-induced hormones called exerkines. While research into exercise and
exerkines as medicines continue to grow, methods to longitudinally quantify exercise efficacy remain to be
elucidated. This research builds tools and methods to track exercise efficacy using metabolic imaging.
We hypothesize that exercise in mice will result in activation of brown adipose tissue (BAT). This metabolic
activation can be detected using hyperpolarized magnetic resonance imaging (HP-MRI). HP-MRI is a cutting-
edge metabolic imaging platform that can quantify metabolic flux. HP is a method that increases the sensitivity
of non-radioactive, stable carbon-13 labeled molecules, such as [1-13C] pyruvate. This increased sensitivity
enables detection of pyruvate conversion to lactate, as well as bicarbonate as surrogate markers of metabolism.
Therefore, we hypothesize that HP-MRI will enable non-invasive detection of BAT activation, due to exercise
and exerkine exposure.
In Aim 1, we longitudinally track BAT activation in a mouse model of exercise using HP-MRI. We pioneer the
development of two different HP imaging probes, [1-13C] pyruvate and diethyl-[1-13C]-α-ketoglutarate (DE--KG).
We will then compare HP-MRI with gold-standard plasma exerkine measurements, to confirm metabolic
activation.
In Aim 2, we extend our experiments to use HP-MRI in offspring of exercised mice. Finally, we ask if HP-MRI
can detect metabolic changes in offspring challenged with high-fat, high-fructose diets. Taken together, our Aims
provide conceptual and technical innovation, pioneering a non-invasive imaging method to study the effects of
exercise in pregnant mothers and their offspring.
To ensure success, our research team consists of a unique combination of expertise in biochemistry, imaging,
and exercise biology. Successful completion of the aims will have a major impact on our understanding of the
long term effects of exercise, in both pregnant mothers and their offspring, well into adulthood.

Public health relevance
Exercise is now seen as an effective therapy for many diseases. In pregnant mothers, the benefits of exercise can extend beyond the womb, to affect the health of children long into adulthood. This research develops tools that uses body scanning methods to measure the benefits of exercise in pregnant mice and their offspring.